MALDI imaging of glial scar-forming glycans in Alzheimers disease

Alzheimer’s disease (AD) is a dementing disorder characterized by the pathological accumulation of beta-
amyloid (Ab) and hyperphosphorylated tau neurofibrillary tangles (NFTs). Recent evidence suggests a close
topographical relationship P-tau accumulation and neuronal loss with changes in gene expression mediating
chondroitin sulfate (CS) and dermatan sulfate (DS) glycosaminoglycan (GAG) metabolism. CS/DS-GAGs are
extracellular polyanionic polymers that have previously been shown to interact with P-tau and Ab, although the
underlying molecular mechanisms and physiological consequences for these interactions remain unclear.
Studies that investigate the relationship between changes in brain CS/DS-GAGs and AD-associated pathological
endpoints are therefore necessary to elucidate a novel role for glycans in the clinical pathogenesis of AD.
The biological functions of extracellular CS/DS-GAGs are highly influenced by the incorporation of sulfated
disaccharide isomers (0S-, 4S-, 6S-, 2S6S-, 4S6S-CS and 2S4S-DS) into the glycan matrix lattices. Often
referred to as the biological “sulfation code”, the relative abundance of non-, mono- and di-sulfated CS/DS
isomers is believed to control ion buffering, protein-glycan interactions, and neurocircuit synapse stability in the
brain. Using state-of-the-art liquid chromatography tandem mass spectrometry (LC-MS/MS), our Preliminary
Data show a significant increase in the relative abundance of glial scar-associated isomers (6S- and 4S6S-CS)
within the medial frontal gyrus of patients with AD compared to non-AD controls. Moreover, these glial scar-
associated CS isomers positively correlate with the abundance of P-tau from the same brain tissue, suggesting
that changes in the brain CS/DS-GAG sulfation code could serve as a novel and unexplored player in the
progression of AD. Specifically, we hypothesize that the increase in glial-scarring CS/DS-GAGs may represent
1) a physiological CNS barrier to isolate P-tau neuropathology from the healthy brain tissue and 2) a repressor
of neurogenesis and source of cellular toxicity, potentially exacerbating neurodegeneration in AD. Here, we
propose to uncover the spatial distribution of CS/DS isomers with the underlying cellular (neuronal, glial) and
pathological (P-tau, Ab) tissue pathology by coupling matrix assisted laser desorption ionization (MALDI) mass
spectrometry imaging (IMS) of CS/DS isomers with histochemical protein labeling using advanced High
Definition Imaging (HDI) overlay technology. Deciphering a relationship between maladaptive changes in the
brain CS/DS-GAG sulfation code and development of AD pathology is a novel and unexplored area of glycan-
based neuroscience with the potential to revolutionize the field of AD research.

Public health relevance
Alzheimer’s disease (AD) is a cognitively debilitating neurodegenerative disorder that affects over 5 million Americans in modern society. Studies outlined within this proposal are designed to clarify the spatial relationship between changes in extracellular glycosaminoglycan sulfation surrounding brain cells and toxic neuropathology in patients with AD by using a novel mass spectrometry imaging technique capable of spatially resolving these glycan sulfation changes with the underlying tissue pathology. Data from this proposal will shed new light on the interactions between glycans and AD neuropathology in humans and provide critical insights regarding an active role for glycans in this neurodegenerative disorder.